Probabilistic Deep Learning Cervical Lymph-Node Auto-Segmentation For Imaging-enhanced Evaluation of Extracapsular Extension Risk (PDL-CLASIFIER)

PROJECT SUMMARY
Head and neck cancer (HNC) is a growing public health concern in the US, with an increasing number of cases
of Human Papillomavirus associated Oropharyngeal cancer (HPV+ OPC). Locoregional therapy in the form of
surgery and/or radiation therapy (RT) is often successful in treating HPV+ OPC, but the resulting damage to
normal tissue can lead to a decreased quality of life (QOL) for survivors. To improve treatment planning for
HPV+ OPC patients, we aim to use artificial intelligence (AI) to accurately identify patients who can benefit
from curative trans-oral robotic surgery (TORS) without adjuvant therapy. Currently, identifying HPV+ OPC
patients that can benefit from TORS without adjuvant therapy is based on ad hoc estimation of risk factors for
adjuvant therapy, including tumor resectability and the presence of extracapsular nodal extension (ENE). ENE
is often used as an indicator for the requirement of adjuvant therapy and plays a critical role in patient risk
stratification and decision-making for treatment planning. To address the issue of accurately identifying ENE in
HPV+ OPC, we will develop AI methods with performance that meets or exceeds segmentation and detection
accuracy of metastatic lymph nodes (MLNs) and ENE using pretreatment imaging/clinical data. This approach
has the potential to enable clinicians to make better-informed decisions regarding treatment planning, which
can ultimately lead to better outcomes and improve the QOL for HPV+ OPC survivors. Current approaches to
identify ENE radiologically using diagnostic imaging such as computed tomography (CT), magnetic resonance
imaging (MRI), and positron emission tomography (PET) are unsatisfactory for robust clinical implementation.
To address this issue, we will combine novel deep learning (DL) approaches for 3D multi-modality
(PET/contrast-enhanced CT [CECT]) medical image segmentation and classification with predictive uncertainty
approximation methods, i.e., probabilistic DL (PDL), and evaluate models against human performance for
clinical acceptability. The central hypothesis of this research is that PDL methods can incorporate pretreatment
multi-modal anatomical and functional imaging (PET/CECT) with clinical data to provide probabilistic
segmentation of MLNs and ENE detection with high accuracy and quantified level of confidence that is
sufficient for clinical decision making. Therefore, if successful, this approach would redefine the standard-of-
care regarding TORS/definitive RT treatment planning for HPV+ OPC patients. The proposed AI-assisted
approach aims to improve the accuracy of risk stratification for HPV+ OPC patients by identifying ENE more
accurately and providing a more precise risk assessment. This approach has the potential to enable clinicians
to make better-informed decisions regarding treatment planning, which can ultimately lead to better outcomes
and improve the QOL for HPV+ OPC survivors.

Public health relevance
PROJECT NARRATIVE Clinical decision support tools for oropharyngeal cancer (OPC) using diagnostic imaging and clinical data have the potential to improve metastatic cervical lymph node auto-segmentation and extracapsular nodal extension detection, which could subsequently guide actionable treatment planning for improved efficacy with minimal side effects. We propose novel probabilistic deep learning methods that can simultaneously detect, segment, and classify of metastatic lymph nodes using pretreatment multi-modality imaging and clinical data with patient- specific probabilistic estimation of segmentation and classification accuracy. These advancements would improve public health by enhancing the accuracy of the risk stratification of OPC patients for appropriate treatments, ultimately improving treatment outcomes and quality of life of OPC survivors.